Advancing FGF13-Nav1.6 modulators to normalize Nucleus Accumbens activity for Cocaine Use Disorder

ABSTRACT
Cocaine use disorder (CUD) is a national public health emergency in the United States for which there are no
FDA-approved medications. It is a chronic condition with a high relapse risk, driven by increased sensitivity of
the mesocorticolimbic system to cocaine. At the circuitry level, relapse has been associated with excessive firing
of nucleus accumbens (NAc) medium spiny neurons (MSNs). In these cells, firing is regulated by the voltage-
gated Na+ channel Nav1.6 and its subunit, fibroblast growth factor 13 (FGF13). Recent findings from the IonTX
team show that in vivo silencing of FGF13 in the NAc increases Nav1.6 currents and MSN firing, leading to
reduced cocaine demand in a rat CUD model. Based on this, IonTX has identified a novel small-molecule
enhancer of the FGF13/Nav1.6 complex, with plans to optimize it into a first-in-class CUD medication aimed at
reducing relapse vulnerability. Through a validated multi-tier screening pipeline, initial optimizations of the hit
compound 5788 have been performed, building meaningful structure-activity relationship (SAR) studies.
Combining results from various assays and pharmacokinetic (PK) studies, the fast-fail strategy aims to expand
the lead optimization campaign. The goal of this project is to conduct structure-activity relationship (SAR)
analysis and optimization of compound 5788 (Aim 1), followed by pharmacokinetic (PK) studies of 5788
analogues (Aim 2), and in vivo efficacy studies using the rat cocaine self-administration model combined with
quantitative electroencephalogram (qEEG) (Aim 3). Positive outcomes of these studies will form the basis for a
risk-benefit assessment with pre-IND enabling preclinical studies for future pre-IND meeting with the FDA and
entry into clinical trials. The goal is to identify a candidate with improved drug-like properties by the end of the
12-month budget period for future IND-enabling studies to treat CUD.

Public health relevance
PROJECT NARRATIVE Cocaine-use disorder (CUD) is a national public health emergency in the United States for which there are no FDA-approved medications. IonTX Inc. has discovered and validated a candidate compound with promising activity against a new druggable target mechanistically linked to CUD. The goal of this project is to conduct preclinical studies on the candidate compound and optimized analogues that could lead to new medication development against CUD.